Unraveling how neuropathic pain synaptic transcriptome is signaled by G-quadruplex folds

PROJECT SUMMARY
Neuropathic pain is a pervasive and debilitating condition associated with modifications in synaptic
plasticity and altered gene expression within the spinal cord. However, the specific molecular mechanisms
underlying these synaptic changes remain poorly understood. This proposed project aims to unravel the synaptic
transcriptome modifications occurring during neuropathic pain and investigate the involvement of G-
quadruplexes in translocation of transcripts at the synapse. The outcomes of this study will provide a
comprehensive map of the synaptic transcriptomic changes in neuropathic pain and elucidate some of the factors
contributing to this alteration. Furthermore, it will pave the way for the development of innovative therapeutic
strategies targeting the G-quadruplexes, ultimately offering new avenues for the management of neuropathic
pain.

Public health relevance
PROJECT NARRATIVE The current proposal aims to examine the changes in the synaptic transcriptome of the primary- secondary sensory afferents structure occurring in the spinal cord during synaptic gain of function in neuropathic pain. Completion of this work will yield a comprehensive map of the transcriptomic changes that occur in the synapse during neuropathic pain and examine the factors that contribute to this highly polarized transcriptomic population. Targeting of those factors will yield new therapeutic avenues for neuropathic pain.